Molecular mechanism of heterochromatin formation

Project Summary
Eukaryotic heterochromatin is demarcated by histone H3 lysine 9 methylation (H3K9me) and is required for
maintaining genomic stability. Loss of heterochromatin results aneuploidies and translocations and is associated
with human diseases including cancers. The centromeres of the fission yeast, Schizosaccharomyces pombe,
have served as a powerful model for uncovering the conserved chromatin- and RNA-based mechanisms
governing heterochromatin formation. Historically, in this system, the recruitment of the highly conserved
Suv39/Clr4, the sole histone H3 lysine 9 (H3K9) methyltransferase, to centromeres was thought to be guided by
Argonaute-associated small RNAs (sRNAs) generated by processing of heterochromatic transcripts by the RNAi
machinery. Additionally, the two highly conserved heterochromatic histone deacetylases, Sir2 and Clr3,
deacetylate histones and prepare histones for Clr4-mediated methylation. Once targeted, Clr4 can not only
methylate H3K9 but also bind to this mark, thus creating a positive feed forward loop, stabilizing its interaction
and spreading along heterochromatin. Even though how centromeric heterochromatin is nucleated has been
topic of many studies, all models converge on sRNAs as the only mechanism for nucleating Clr4 and triggering
heterochromatin formation. My team on the other hand, inspired by the 20-year-old observation that in ago1D
cells H3K9me is reduced but not eliminated at pericentromeres, asked whether an sRNA-independent
mechanism could nucleate Clr4. In recent Cell paper, we define an sRNA-independent alternative axis to
heterochromatin nucleation. This pathway uses the nuclear RNA quality control complex, MTREC which interacts
with Clr4 and specifically recognizes a heterochromatic long noncoding RNA (lncRNA) called SPNCRNA.230
bivalently, via its Mmi1 (YTH-domain protein) and Mtl1 (RNA-helicase) components. More importantly, loss of
MTREC together with RNAi leads to complete loss of Clr4 recruitment at centromeres, revealing that these two
pathways operate in parallel to nucleate Clr4. Additionally, we showed that Sir2 and Clr3 work upstream of Clr4
to deacetylate H3K9 for Clr4 methylation and are recruited to pericentromeres, including SPNCRNA.230, by
sRNA-independent mechanisms. Overall, these data reveal that three independent mechanisms amass Sir2,
Clr3 and Clr4 at SPCNRNA.230 to nucleate and trigger heterochromatin formation. Here, we will (Aim 1)
Decipher the mechanism(s) of Sir2 recruitment to heterochromatin; (Aim 2) Delineate how SPNCRNA.230
nucleates Clr4 and Clr3 independently of sRNAs and H3K9me; and (Aim 3) Reveal the mechanisms of lncRNA-
mediated heterochromatin assembly using an inducible system. Overall, the proposed studies will reveal how
distinct, parallel recruitment mechanisms nucleate heterochromatin machinery at lncRNAs to trigger
heterochromatin formation. We predict that these studies will reshape our understanding of heterochromatin
mechanisms and expose novel targets for manipulating heterochromatic state in eukaryotes.

Public health relevance
Project Narrative The human genome contains many repetitive DNA regions which must be maintained in a `silent' state to preserve genomic integrity, suppress mutations and prevent several human pathologies, including cancers. The goal of this project is to decipher how cells establish silencing at repetitive regions using the highly malleable fission yeast as a model. Because of the conservation of these silencing factors from yeast to human cells, we predict that these studies will yield molecular insight and may reveal therapeutic targets that can be exploited to combat cancer.